Wnt Signaling and Endosomal Trafficking as Regulators of Cellular Protein Degradation

Project Summary/Abstract There is a fundamental gap in our understanding of the basic mechanisms underlying the regulation of cytosolic protein degradation. A portion of cytosolic proteins are engulfed by endolysosomes through a process known as microautophagy, however, the extent to which microautophagy can be regulated and which specific proteins are targeted through this mechanism are unknown. This gap represents an important problem because the misregulation of cytosolic protein turnover is a critical component of neurodegeneration and represents an emerging theme in cancer research. The long-term objective of this project is to determine the how protein catabolism is regulated by Wnt signaling, a pathway that is essential in development and is misregulated in disease. My preliminary data support the conceptually novel hypothesis that microautophagy is coordinated by canonical Wnt. Further, preliminary data suggests that cytosolic substrates targeted by microautophagy during Wnt signaling are modified by arginine methylation, a critical post-translation modification recently implicated in cytoplasmic signaling. Based on these findings, the central hypothesis of this proposal is that Wnt signaling stimulates arginine methylation to promote cytosolic protein degradation in endolysosomes through microautophagy (Fig. 1). I propose two specific aims: (1) elucidate the role of arginine methylation in Wnt signaling during cell growth and embryogenesis; and (2) determine how Wnt signaling and microautophagy regulate cytosolic protein degradation in endolysosomes. Aim 1 will examine the roles arginine methylation and Protein Arginine Methyl-Transferase 1 (PRMT1) in promoting Wnt signaling during cell growth and embryogenesis in human cells and Xenopus. Aim 1 is conceptually innovative as it examines a novel role for arginine methylation, a modification only recently discovered in cytoplasmic signaling, in the Wnt pathway and endolysosomes. Further, technical innovation through the use of chemical- genetic protein labeling strategies will offer the highest levels of sensitivity to examine the role of methylation in promoting GSK3 phosphorylation in live cells. Aim 2 will define the mechanism through which Wnt signaling regulates microautophagy to promote cytosolic proteolysis using genetic biochemical approaches to assess endolysosomal proteolysis in cultured human cells. I will apply a technically innovative in vivo biotin-protein labeling strategy to examine the novel concept that microautophagy targets specific cytosolic proteins during Wnt signaling. The proposed research is significant because elucidating the regulation of cytosolic proteolytic pathways could contribute to the development of innovative therapeutic interventions for targeting Wnt signaling in cancer and may reveal key details into the mechanisms of protein degradation in disease. In sum, this proposal offers a novel approach to investigate an integrated view of the pathologic mechanisms of protein degradation regulated by extracellular signaling factors during development and tissue morphogenesis.

Public health relevance
Project Narrative This proposal addresses fundamental concepts that are relevant for public health by investigating the underlying molecular mechanisms of Wnt signaling, an essential pathway for human development that is misregulated in disease. These studies examine a novel role for Wnt signaling in the regulation of how cellular proteins are broken down, which represents a common mechanism that is central to the progression of neurodegeneration, cancer, and cardiac disease. The proposed research will advance the NIH's mission to improve the health of the Nation by revealing new opportunities for biomedical research of human development and birth defects and by elucidating a novel signaling link that could play a central role in cancer and in diseases with protein aggregation.